Development of an Ultrasensitive, Rapid and Easy-to-Use At-Home Molecular Test for HCV, HBV AND HIV

Multiplexed Patient Administered Diagnostics for Hepatitis B, Hepatitis C, and HIV: HIV and viral hepatitis infections share common modes of transmission and social and structural barriers to accessing care and services among key populations. Coinfection with HIV significantly impacts the pathogenesis of HBV and HCV and is associated with reduced spontaneous clearance of HCV and HBsAg, higher rates of chronicity and occult HBV, higher HCV viral loads, rapid disease progression, and increased risk of morbidity and mortality due to cirrhosis and HCC. Integrated strategies for screening and diagnosis of HIV and viral hepatitis infections are therefore critical to an effective global health response. This contract aims to develop a nucleic acid amplification test for detection of HIV and HBV from whole capillary blood using the Cubit platform.